Wildfires and Cardiovascular Health: Evaluating Associations and Intervention Strategies

Summary RPL Walker, Wildfires and Cardiovascular Health: Evaluating Associations and
Intervention Strategies
Wildfires are a growing public health crisis as they increase in size, intensity, and duration across the United
States (US). There is a critical need for the development and evaluation of intervention strategies that reduce
wildfire exposures and improve health outcomes. We will leverage ongoing partnerships with clinical
researchers in Montana to study the impact of wildfires on cardiovascular health and evaluate the
implementation of a novel air pollution intervention among patients with cardiovascular disease. For this project
we will pursue the following specific aims. First (Aim 1), we will assess associations between modeled ambient
air pollution and health among cardiovascular patients in Montana. We will assess associations between
modeled ambient fine particulate matter (PM2.5) and cardiovascular hospitalizations at the zip code level (data
2010-2022) and procedures of percutaneous coronary intervention (PCI) at the address level (data 2018-
present). Our hypothesis is that ambient PM2.5 will be adversely associated with cardiovascular hospitalizations
and incidence of PCI in Montana. Second (Aim 2), we will develop an expert panel-informed strategy to
improve residential indoor air quality. The AIRWISE intervention utilizes portable air cleaners (PACs) to filter
indoor air with enhanced aspects focusing on improving PAC compliance. Key components include low-cost
sensors that change color according to air quality index (AQI) and behavioral recommendations that
correspond to varying AQI levels. Third (Aim 3), we will evaluate AIRWISE acceptance and compliance (Aim
3a) and assess associations between residential indoor PM2.5 and cardiovascular health (Aim 3b). We will
administer the AIRWISE intervention to 20 PCI patients recruited from a local cardiovascular clinic and
evaluate intervention acceptance and compliance over a 6-month period spanning the 2024 wildfire season in
Montana. Our Aim 3a hypothesis is that education and color-changing sensors will increase knowledge and
awareness of air quality among participants and lead to improved intervention compliance. We will also
prospectively collect health measures to calculate a metric called Life’s Essential 8 (LE8), a construct of
cardiovascular health including blood pressure, lipids, glucose, body mass index, nicotine exposure, diet,
physical activity, and sleep health. We will assess associations between the LE8 metric and indoor PM2.5
concentrations. Our Aim 3b hypothesis is that the LE8 metric will decrease as household-level PM2.5 increases.
Altogether, the aims proposed here will provide extensive preliminary data and create an excellent platform for
a future R01 proposal for a randomized trial aimed at reducing air pollution exposures and improving
cardiovascular health. This research focuses on a clinically vulnerable population in a wildfire-impacted state,
and addresses ongoing calls for improved research related to wildfires and cardiovascular health.